Investigating the Heterogeneous Intercellular Signaling of Hematopoietic Stem and Progenitor Cells and its Changes around the Circadian Clock

PROJECT SUMMARY
Blood regeneration must constantly adapt to bleeding, infection, injury, and disease. These processes rely on
cell-cell communication to hematopoietic stem cells, HSCs, that are responsible for maintaining the homeostasis
of the blood and immune systems. To fulfill this role, HSCs must engage in cell-cell communication with the
surrounding cells in the bone marrow. Previous studies have demonstrated that some of these cells, including
mesenchymal cells, vascular cells, and osteoblasts, referred to as their niche, play significant roles in regulating
and maintaining HSCs via signaling pathways like KIT, CXCL, and VCAM. In these pathways, HSCs play the
role of receiver by expressing the receptors for the ligands the niche cells produce. Several studies have
suggested that HSCs play active roles in signaling within the bone marrow as well. Not only do they express the
receptors for the ligands their niche produces, but they also secrete ligands to their microenvironment. However,
individual HSCs do not have even access to these ligands in the dense, semi-fluid, heterogeneous bone marrow
environment. This observation, coupled with the fact that gene expression within HSPC populations is
heterogeneous, suggest significant signaling heterogeneity in the bone marrow. From my preliminary studies,
HSCs exhibit heterogeneous signaling patterns with their niche, immune cells, and other hematopoietic
progenitor cells (HPCs), some of which significantly correlate across individual cells. Further, it has been shown
that HSPC homing to the bone marrow niche significantly alters with the circadian clock and preliminary data
suggests circadian rhythms modulate gene expression and signaling in a lineage-specific manner. Given these
preliminary findings, I hypothesize that individual HSPCs are engaged in diverse intercellular signaling
pathways in the bone marrow that coordinate with each other and alternate around the circadian clock.
The goal of this project is to better understand cell-cell signaling in the bone marrow between HSPCs and their
microenvironment and how these signals influence their cell fate decisions and change around the circadian
clock in the following three Specific Aims. Aim 1. To use single-cell RNA-sequencing data from HSPCs, their
niche, and mature immune cells paired with single-cell spatial data from bone marrow to predict cell-cell signaling
pathways. Aim 2. Determine intercellular signaling correlations to construct cell-cell signaling networks. Aim 3.
Determine the impact of the circadian clock on HSPC’s intercellular signaling and production of blood and
immune cells. In doing so, I will establish a compendium of potential pathways that influence HSPC fate decisions
and elucidate the impact of circadian rhythms on HSPC signaling and blood and immune production.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cells are responsible for life-long blood regeneration and, as such, are regarded as the most important cell types for regenerative medicine. The proposed research will study how cell-cell communication in the bone marrow regulates the production of blood and immune cells and how cell-cell signaling changes around the circadian clock. Potential findings can help understand physiological response to bleeding, infection, and disease, and may reveal new therapeutic targets for blood and immune disorders.